Dissecting virulence gene regulatory pathways in M. tuberculosis clinical isolates

Project Summary
Infecting an estimated one quarter of the world’s population, M. tuberculosis (Mtb) is an ongoing threat to human
health worldwide. Mtb infection can lead to a wide range of outcomes ranging from an asymptomatic latent
infection to severe disease. These disease states are the function of bacterial, host, and environmental factors.
Despite ongoing selection to adapt to the host environment, the contribution of Mtb’s genetic variation is an
underappreciated variable in this equation.
Evolution acts on regulation of gene expression to create large phenotypic diversity from small genetic change.
Our long-term objective is to understand how evolution in Mtb’s regulatory network contributes to variation in
disease outcome. In a preliminary study, we used a high-throughput transcriptomic pipeline we built to capture
transcriptomes from 284 clinical isolates from Vietnam and Peru; we identified ~10% of well-transcribed genes
were highly variable across isolates and linked expression outliers to mutations in transcriptional regulators or
nearby regulatory regions. Unexpectedly, we identified an up to 17-fold range in expression of ESX-1 secreted
effector proteins; a key virulence pathway, ESX-1 is required for productive infection. Based on these results,
we propose two aims for this study. In Aim 1, since transcriptional regulation responds to the environment, we
will capture transcriptomes from our isolate library during in vitro acid stress and hypoxia, environments from
establishment of infection and survival in granuloma, respectively. By searching for convergent evolution in gene
expression across the phylogenetic tree, we will identify expression programs and genetic variants that drive
adaptive change in host. In Aim 2, we will build on our discovery of ESX-1’s expression variation and integrate
natural variants driving four distinct expression states across two secreted effector operons. Next, we will use
these engineered strains in a macrophage and mouse model of infection to determine if and how they drive
different disease phenotypes.
Mtb is under constant selective pressure to survive the host environment. This work uses Mtb’s natural variation
to illuminate the genetic pathways and molecular strategies that evolution bends to this goal. This work will
explore the mechanisms of Mtb genetic variation that contribute to variable disease outcomes. It is critical that
we expand our understanding of pathogens beyond a few strains: if we limit ourselves to laboratory strains, we
risk designing treatments that will not work outside the laboratory.

Public health relevance
Project Narrative Though M. tuberculosis (Mtb) is under ongoing selection to adapt to the human host environment, the contribution of Mtb genetic variation to host disease is largely unexplored beyond antibiotic resistance. Using a library of Mtb clinical isolates, we designed a high-throughput RNA-sequencing pipeline to quantify gene expression variation in bacteria and link it to genetic change. Using this method, this study will characterize how evolution tunes the Mtb transcriptional regulatory network to create adaptive change and determine if and how evolution of the key virulence pathway, ESX-1, changes host response to infection.